Iowa Medical Student Summer Research Program in trans-NIDDK Research

Since its origins nearly 60 years ago, the Iowa Medical Student Summer Research Program has continuously
evolved to sustain its mission of enveloping medical students in mentored research opportunities that foster
their development into accomplished physician-scientists that positively impact human health. The last six
years have demonstrated unprecedented success in the level of student engagement and productivity with
ongoing achievement in the recruitment and retention of students from underrepresented groups. It is against
this backdrop of accelerated growth and diversification that we propose to sharpen our focus and deepen our
students' engagement with an exceptional cadre of enthusiastic mentors performing scientifically rigorous
trans-NIDDK research focused on digestive and liver diseases; endocrine and metabolic diseases; obesity and
nutritional disorders; or kidney and urologic diseases. Those four areas of investigation are long-standing
institutional strengths, and with seed funding from our College of Medicine, we have begun transitioning our
historically successful campus-wide single-stream funding model into a re-envisioned program with the same
high level administrative infrastructure now leveraged to selectively enhance recruitment and support of a
diverse cohort of M1 students that are committed to a summer of immersive research with our curated roster of
42 outstanding and experienced Participating Faculty on a project within the research mission of the NIDDK.
This training grant proposal seeks transformative funding for 16 students to participate in 12-week summer
fellowships, and the funds provided through this training grant would be matched by the College of Medicine,
amplifying the impact of the award. In synergy with extensive opportunities provided through relevant Centers
and Institutes, scholars will receive Instruction in Methods for Enhancing Reproducibility and the Responsible
Conduct of Research, as well as mentor-guided journal clubs and research seminars. In the years that follow,
students enroll in our research skills course, year-long research opportunities, the Research Distinction Track,
and dual degree programs. We closely monitor students alongside their mentors as they continue their
pathway towards a research career with incremental advancement through the continuity of support that is
available at our institution, including funding during residency, fellowship, and junior faculty appointments. We
critically evaluate every aspect of our extensive programing each year through a combination of anonymous
surveys and collaborative discussions to continuously enhance the exposure of our students to the entire
research process, from writing a proposal to analyzing data, presenting at local and national meetings, and
ultimately disseminating the results in peer reviewed journals. The long-term impact of this program is the
development of a diverse cohort of physicians that are equipped to extend their discoveries into real-life
applications that improve human health through prevention and improved treatment for gastrointestinal,
endocrine, metabolic, nutritional, renal and urologic disease.

Public health relevance
Physicians from underrepresented minorities and diverse backgrounds bring unique perspectives, but they remain significantly underrepresented in biomedical research. Early research exposure is a key component to increasing and sustaining the participation of medical students in research careers. This proposal features highly engaged faculty and strong institutional support to promote long-term medical student involvement in research dedicated to the prevention or mitigation of digestive and liver diseases, endocrine and metabolic diseases, obesity and nutritional disorders, or kidney and urologic diseases.